A RANDOMIZED DOSE-RESPONSE STUDY TO ASSESS THE SAFETY AND PRELIMINARY EFFICACY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to: 1. Evaluate the effect of the medication, Darbepoietin, on red blood cell count and anemia. 2. To observe any side effects among very low birth weight [VLBW] infants who receive 1 of 3 doses of Darbepoietin..